Targeting Bcl-2 Family Proteins to Facilitate Fibroblast Apoptosis and Promote the Resolution of Pulmonary Fibrosis

Project Summary/Abstract
This project aims to understand and control the anti-apoptotic mechanisms employed by fibroblasts to evade
apoptosis during the fibrotic process. Pulmonary fibrosis is a devastating disease affecting millions worldwide.
Profibrotic fibroblasts are key effector cells in fibrosis, which lay down collagen and can contract to deform
tissues. In normal wound healing, fibroblasts undergo apoptosis and are cleared, but in pathologic fibrotic
diseases fibroblast resistance to apoptosis allows them to persist and contribute to progressive and non-
resolving fibrosis. The intrinsic pathway of apoptosis is controlled by the Bcl-2 family of proteins. It is known that
in pulmonary fibrosis, fibroblasts have increased levels of the anti-apoptotic protein Bcl-2. However, there are
more than 15 Bcl-2 family members some of which are pro-apoptotic and some anti-apoptotic. Therefore,
understanding the apoptotic milieu of a cell requires more than simply measuring the levels of one Bcl-2 family
protein. In this proposal we will use cutting edge laboratory techniques to delineate the anti-apoptotic
strategy employed by profibrotic fibroblasts and leverage this behavior to induce fibroblast apoptosis
and resolution of pulmonary fibrosis. We will use primary lung fibroblasts cultured in vitro to explore the Bcl-
2 family interactions in fibroblasts using human and murine fibroblasts isolated from healthy and fibrotic lungs.
In Specific Aim 1, we will elucidate the Bcl-2 family protein levels, expression, and interactions in both the healthy
and fibrotic state, and determine if fibroblasts from fibrotic lungs are more resistant to intrinsic pathway driven
apoptosis. We will then evaluate the effects of inhibition and knockdown of anti-apoptotic proteins on fibroblast
apoptosis. In Specific Aim 2, we will use two in vivo models of persistent pulmonary fibrosis in mice (silica and
repetitive bleomycin) to explore the effects of Bcl-2 inhibition with the drug ABT-263 on fibroblast apoptosis and
pulmonary fibrosis. We will measure fibrosis with micro-CT, histology, and hydroxyproline levels. Using mice with
tamoxifen-inducible expression of the red fluorescent protein tomato under the control of the aSMA promoter,
we will track and quantify fibroblasts during and after treatment. Our work will provide a greater understanding
of anti-apoptotic mechanisms employed by fibroblasts and explore a viable therapeutic option to induce fibroblast
apoptosis. Our work will significantly add to our understanding of how the intrinsic pathway of apoptosis controls
the resolution and persistence of fibrosis and will potentially identify targets for therapeutic intervention.
My mentors and I have created a structured training plan that will provide training in the following domains:
question and hypothesis building, development of experimental approaches, basic and advanced cutting-edge
lab techniques, data evaluation and interpretation, data presentation and manuscript preparation, oral
presentation skills, and grant preparation and grantsmanship. This project will be carried out in the highly
collaborative environment at National Jewish Health, which serves as an outstanding platform on which to build
a career as an independently funded physician scientist.

Public health relevance
Project Narrative Fibroblasts are the effector cells of fibrotic disease and in fibrotic diseases become resistant to apoptosis, allowing them to persist and propagate scarring. With this project we will gain an understanding of the anti- apoptotic mechanisms employed by fibroblasts during fibrosis and use a clinically available therapeutic to induce fibroblast apoptosis which we hypothesize will result in the resolution of fibrotic disease. Pulmonary fibrosis carries a dismal prognosis with limited therapies available, thus our work will provide valuable information regarding anti-apoptotic behavior of fibroblasts and the ability to target these cells to die as a therapeutic avenue.